Impact of Chronic Seizures on Neuropsychiatric Comorbidities in AD-Associated Models

Abstract:
Autosomal dominant early-onset Alzheimer's disease (ADEOAD) is associated with numerous
genetic mutations, including those in amyloid precursor protein (APP), and presenilin (PSEN) 1
and 2 genes. Growing evidence indicates that patients with AD often experience undiagnosed
focal seizures. Indeed, over 30% of AD patients with the most common PSEN2 gene variant
(N141I) report seizures and patients with APP duplication have a similarly high incidence of
reported seizures, suggesting an unexplored role of hyperexcitability in the pathophysiology of
AD. Both epilepsy and AD are associated with numerous neuropsychiatric comorbidities.
Limited clinical evidence suggests that AD patients with reported seizures may have worsened
long-term disease trajectory. However, few studies have directly addressed how chronic
seizures in the presence of AD-associated risk genes affect long-term neuropsychiatric and
behavioral comorbidities. Even less data exists to directly define the age-dependent impact of
chronic seizures on neuroplasticity processes, which may also underlie neuropsychiatric
comorbidities of AD. This proposal will thus demonstrate how chronic seizures age-dependently
impact neuropsychiatric comorbidities and neuroplasticity-associated protein expression in
several preclinical models of AD that do and do not demonstrate amyloid-beta accumulation
(APP/PSEN1 and PSEN2-N141I, respectively). This proposal will definitively address whether
and when chronic seizures impact the functional and neuropathological sequelae of AD so as to
elucidate whether seizures are a contributor to worsened AD trajectory. It is currently unclear
when in the course of AD seizures occur. It is also unclear whether these seizures exacerbate
neuropsychiatric symptoms associated with AD. ADEOAD-risk genes represent underexplored
molecular contributors to network hyperexcitability, which may accelerate disease progression
in the context of AD. The major goal of this project is to thus define the age-dependent additive
impact of ADEOAD-associated risk factors and chronic seizures on the development and
severity of neuropsychiatric comorbidities and neuroplasticity-associated protein expression.

Public health relevance
Patients with Alzheimer’s disease (AD) experience seizures, although these events are commonly non-convulsive in nature and thus potentially missed. Despite this, little is known regarding the direct long-term impact of untreated seizures on disease progression in patients with AD. This study will directly define whether chronic seizures age-dependently aggravate neuropsychiatric comorbidities of AD.